High-Throughput 3D Multiscale Mass Spectrometry Imaging for Understanding Neurochemical Heterogeneity in Alzheimer's Disease

PROJECT ABSTRACT:
Understanding Alzheimer’s disease (AD) and identifying effective interventions are among the most
exciting scientific frontiers and most critical healthcare challenges. While the roles of several
pathological hallmarks of AD have been extensively studied, the biochemical alterations associated with
these hallmarks and the mechanisms underlying progressive neuron loss and neuronal vulnerability in
AD are not fully understood. Neurogenesis, a unique characteristic of the hippocampal formation, has
been shown to play important roles in aging and AD progression. Abnormal early declines in
neurogenesis have been observed in AD brains in both human and animal models, but the molecular
profile of alterations in vulnerable brain circuits and neurons associated with varied neurogenesis have
not been documented. Fourier transform mass spectrometry imaging (MSI) and single cell analyses
allow for mapping and profiling hundreds to thousands of molecules in biological samples and single
cells, providing unparalleled chemical insights relevant to AD as discussed above. However, several
major challenges exist: (1) the limited throughput that prohibits the analysis of many tissue slices and
samples; (2) the challenges associated with high-resolution volumetric reconstruction of biomolecular
distributions for regional analysis across samples and experimental groups; (3) the need for integrating
multiscale tissue MSI and single-cell MS data to relate cellular neurochemistry to tissue chemical
heterogeneity. The proposed research addresses these challenges by developing a suite of novel mass
spectrometry-based technologies and uses these technologies to map biomolecules related to AD and
neurogenesis. Aim 1 develops a new technology to significantly enhances the throughput of FT-MSI by
synergizing compressed sensing and deep learning, and a multimodal approach to integrate many MSI
slices for 3D chemical atlases of AD and wild type mouse brain. Aim 2 develops an experimental
framework to generate multiscale tissue MSI and single-cell MS data, a computational framework to
jointly analyze these data, and -omics based molecular libraries to aid in interpreting the MSI and single
cell data. Aim 3 leverages the tools developed in Aims 1 & 2 to determine the temporal and spatial
signature of vulnerable circuits and neurons in a FAD mouse model of AD. Aim 4 investigates the
effects of hippocampal neurogenesis on neuronal vulnerability and AD progression using the new
multiscale MSI technology, as well as creates 3D chemical atlas of the mouse brain. The proposed
research, synergistic with both technology- and hypothesis- driven aims, will expand the technological
envelop of MSI and transform how high-resolution MSI data are generated and analyzed. The proposed
measurements will address critical knowledge gaps on the mechanism underlying neuronal vulnerability
in AD, potentially identifying new biomarkers and therapeutic targets.

Public health relevance
PROJECT NARRATIVE: Novel mass spectrometry-based technologies will be developed to create molecular atlases of the mouse brain impacted by Alzheimer’s Disease and healthy control. The proposed innovations in mass spectrometry imaging and single-cell mass spectrometry measurements and multiscale data fusion, in combination with unique mouse models of Alzheimer’s Disease, will reveal the temporal and spatial signatures of neuronal vulnerability in Alzheimer’s Disease and the effects of hippocampal neurogenesis on disease progression. The spatially and chemically resolved molecule portrait of healthy and Alzheimer’s Disease impacted brains will help elucidate the molecular mechanisms of disease progression and identify new biomarkers and therapeutic targets.